CORE C - COMPUTATIONAL BIOCHEMISTRY & BIOINFORMATICS

CORE C – COMPUTATIONAL CHEMISTRY, BIOPHYSICS & BIOINFORMATICS
ABSTRACT
APOBEC is a well-established enzymatic source of on-going mutation in cancer. The major enzymes
responsible are the cytosine deaminases APOBEC3A (A3A) and APOBEC3B (A3B), which attack the single-
stranded (ss)DNA. Our Program is therefore united in testing the overarching hypothesis that A3A/B inhibition
will prevent a large proportion of new mutations in cancer, thereby improving the durability of current treatments
and resulting in better overall outcomes. Projects 1, 2, and 3 are focused on testing this idea through a carefully
organized multidisciplinary team involving structural biology, chemical biology, and cancer biology approaches,
respectively. Core C – Computational Chemistry, Biophysics & Bioinformatics provides the computational
modeling and informatics backbone to support these Projects through three well-integrated specific aims. Aim 1
encompasses the development of physically detailed 3D structural models of APOBEC biomolecular systems,
including those that prove challenging to resolve experimentally, such as the full-length A3B and different
macromolecular complexes being explored in Projects 1 and 3. In these examples and others, explicitly solvated
molecular dynamics (MD) simulations will be used to predict atomic-level interactions, and these dynamic 3-
dimensional models will guide wet experiments by the Project teams. Innovative MD analysis frameworks, such
as multiscale modeling and residence time optimization, will be used to extract long-timescale dynamics from
many short-timescale simulations and elucidate the thermodynamic and kinetic landscapes of APOBEC
enzymes that control molecular recognition and functional activity. The resulting data will drive Core C to develop
further refined models for additional testing by the Project teams. Aim 2 consists of in silico small molecule
optimization efforts against A3A and A3B. Key strengths of this approach are identification of cryptic pockets that
are capable of binding chemical probes, but are often absent from X-ray structures, and innovation of advanced
simulation methods to predict free energies of binding to drive lead optimization efforts. A range of ligand- and
receptor-based approaches will be employed in silico to increase the structural diversity of APOBEC inhibitors.
Aim 3 provides bioinformatics support through analyzing large-scale next-generation sequencing datasets
generated by the program. We will analyze pan-cancer human genomic, translational, and clinical data in support
of Projects 1-3 and Cores A-B to further our understanding of APOBEC’s roles in cancer. In addition, we will
provide integrative and comparative analysis of genomic sequence data generated by the Program and relevant
publicly available human cancer datasets.

Public health relevance
CORE C – COMPUTATIONAL CHEMISTRY, BIOPHYSICS & BIOINFORMATICS NARRATIVE APOBEC3 enzymes are an enzymatic source of mutations in cancer that promote tumor evolution and reduce the effectiveness of current therapies by generating resistance mutations. Core C – Computational Chemistry, Biophysics & Bioinformatics strengthens this Program’s operations through the iterative development of atomic-level models in real time. The primary goals of Core C are to develop informative 3D structural models of a variety of APOBEC proteins and related macromolecular complexes, to use in silico methods to support lead optimization efforts, and to use informatic methods to analyze and compare genomic data sets to propel the Program toward its long-term goal of inhibiting APOBEC mutagenesis in cancer.